Functional relevance of cardiac regeneration by c-kit positive stem cells

Abstract Heart failure is a growing medical and social problem. Current medical therapies are insufficient to repair the heart and merely postpone death. Stem cell therapy holds promise to be a therapy that could potentially cure heart failure by replacing dead myocardium and scar tissue with new healthy cardiomyocytes. Until a decade ago the heart was considered to be a post-mitotic organ. New findings however, have suggested the heart has some regenerating capacity. Potentially relevant sources of renewal include bone marrow derived cells, such as mesenchymal stem cells, hematopoietic stem cells or endothelial progenitor cells, stem cells residing in the heart, so called Cardiac Progenitor Cells (CPCs) or mitosis by cardiomyocytes. All of these sources are currently being studied, although there is intense debate over the extent to which the heart is capable of regeneration. Currently used models to study cardiac regeneration rely on myocardial infarction, through the induction of a large scar that lacks blood supply. Cardiac stem cells are then isolated and cultured and injected back into the animal to study their salvaging capacities. In this proposal we will take an in vivo approach to study endogenous levels of regeneration. We will investigate regeneration by carrying out the following aims: (1) To examine endogenous stem cell and CPC activation using a novel method for widespread stochastic cardiomyocyte apoptosis throughout the heart. (2) To determine the importance of c-kit positive (cardiac) stem cells for cardiac regeneration using genetically engineered mice. (3) To determine how important cardiac regeneration is for cardiac function as well as assessment of the extent of cellular renewal through a new genetic mouse model to track newly generated myocytes. The initial part of the research proposal will be carried out in the lab or Dr. Jeffery Molkentin, a world renowned cardiac researcher who studies cardiac hypertrophy, calcium signaling and cell death using genetic mouse models. In this lab, I will generate different mouse models to study cardiac regeneration in vivo that I will use to complete the aims proposed here. Moreover, this will provide me with the opportunity to start my independent research career focused on cardiac regeneration. This proposal will open up the field of cardiac regeneration by allowing the study of factors that can enhance the endogenous levels of cardiac repair. Finally, we will begin to determine the relevance of cardiac regeneration for cardiac function and assess the importance of one specific population of stem cells in the process of cardiac repair.

Public health relevance
Project Narrative Heart failure is a growing medical problem for which current medical therapies offer no cure. Cardiac stem cell therapy holds promise to repair the underlying problem of heart failure, myocardial infarction and death. This proposal will study endogenous cardiac repair, determine the extent of it and assess its relevance for cardiac function. __SpecificAimsTextDelimiter__ Specific Aims For years the heart has been viewed as a post-mitotic organ without any regenerative capacity1. However, it is now largely accepted that the heart has at least some regenerative potential2. Generally, three possible sources for renewal have been identified; bone marrow derived stem cells that circulate and 'home' to the injured heart, residing cardiac progenitor cells (CPCs) and proliferation of (small) cardiomyocytes2-10. Although the relative contribution for each of these populations is not known, it is generally assumed that CPCs are the major source of regeneration. Currently, there are no studies that have genetically proven the relevance of certain cells or cell markers for cardiac regeneration in vivo. C-kit+ stem cells, which are developmentally derived from bone marrow, but also reside within the adult heart, have been implicated as a critical population for cardiac regeneration2,3,11,12, although they could also play a role in development of the heart13,14. However, the relevance of this population in mediating myocyte renewal in the heart has been extensively questioned15,16. Therefore, we will examine the hypothesis that the c-kit positive population is a major contributor to cardiac regeneration (although the null hypothesis will also be formally evaluated in case c-kit cells are not overly important). As discussed above, even though many studies have shown that regenerative potential exists in the heart, the mechanisms whereby endogenous regeneration is activated, the functional consequences of regeneration, as well as the relevance of specific subsets of stem cells for regeneration are all unanswered. There is also controversy as to the total extent to which regeneration is possible4,6,17. Another confounding fact is that currently used methods rely on myocardial infarction, a model that is probably not permissive to maximal regeneration due to the hostile environment within a fibrotic scar that often lacks sufficient blood supply to sustain survival of stem cells. Therefore, to reach a better understanding of endogenous stem cell mediated cardiac regeneration, and to be able to assess the functional consequence of cardiac regeneration, we have generated novel mouse models to allow in vivo assessment of stem cell activation and overall regeneration levels. These new mouse models have the potential to revolutionize our ability to define/identify newly formed myocytes in vivo, assess their lineage, and functional importance in vivo without a need for culturing or other isolation based artifacts. The research proposed here will help to establish myself as an independent investigator and has the potential for future funding opportunities. Specific aim 1: To examine endogenous stem cell activation using a novel method for widespread stochastic cardiomyocyte death throughout the heart. We will utilize an inducible system that will not be hampered by scarring and loss of blood supply, creating a completely permissive environment for stem cell activation, engraftment and repair. We will specifically target cardiomyocytes for apoptosis through inducible transcription of diphteria toxin A (DTA). A cardiomyocyte specific tamoxifen inducible Cre transgene will be used to activate DTA randomly throughout the heart at defined levels to produce graded levels of myocyte deletion thereby allowing residing stem cells and bone marrow progenitors to become activated and repopulate the lost cells. Assessment of regeneration will be done by both histology and flow cytometry based techniques to label activation of specific cell markers, characteristic for stem cells. Specific aim 2: To determine the importance of c-kit+ stem cells for cardiac regeneration using genetically engineered mice. We have generated two separate knock-in mouse-based strategies that have either constitutively active or inducible Cre recombinase expression under control of the c-kit locus. Any cell that originates from a c-kit+ stem cell from the moment of activation of Cre will be genetically labeled, when crossed to a genetic reporter. This allows us to unequivocally assess the importance of c-kit+ stem cells for cardiac regeneration after myocardial infarction, but also after physiological exercise and pressure overload. Furthermore, we will assess the relevance of fetal c-kit+ cells for cardiac development. We expect that c-kit+ stem cells have the capacity for cardiac regeneration, but we are unbiased to the extent. Specific aim 3: To determine the relevance of cardiac regeneration for cardiac function through a new genetic mouse model to track newly generated myocytes. We have generated a system in which 2 different cell-cycle specific inducible lines will be used to induce Cre recombinase expression in all newly formed cells. In conjunction with a cardiomyocyte specific genetic reporter line we will tag all newly generated cardiac myocytes in the heart. We will use a cardiomyocyte specific reporter to induce cardiomyocyte death by expressing DTA after we activate the system by tamoxifen treatment, which will kill only newly formed cardiomyocytes. By selectively killing all newly formed cardiomyocytes we will determine the importance of cardiac regeneration for maintaining cardiac function. Simultaneously, we will use a cardiomyocyte specific fluorescent reporter to assess the extent of regeneration from whatever source.